Prevention of CMV infection with a viral IL-10 neutralizing antibody

The goal of this work is to prevent primary CMV infection through prophylactic passive vaccination
with a highly potent CMV IL-10 neutralizing monoclonal antibody. The greatest risk of congenital
cytomegalovirus (CMV) infection, in terms of both numbers of infections and severity of disease, follows from
primary maternal infection during the first trimester of pregnancy. There is no vaccine to prevent congenital
CMV disease, and treatment options are limited due to risk to the fetus. Previous CMV vaccine approaches
have focused on eliciting neutralizing antibody responses against viral glycoproteins, similar to those observed
following infection. Glycoprotein B (gB) has shown some efficacy in CMV seronegative women and is
considered a leading vaccine antigen, as are members of the pentameric complex. However, it is not clear
whether targeting CMV glycoproteins can ever be sufficient to prevent or reduce CMV transmission since
natural immunity to CMV in immune-competent people appears only to protect against clinical disease—not
against (super)infection. We propose to protect against CMV infection by instead targeting the CMV-encoded
IL-10 (cmvIL-10) immunomodulatory gene using a highly potent neutralizing monoclonal antibody.
We hypothesize that a highly potent CMV IL-10 neutralizing monoclonal antibody will provide significant
protection from horizontal primary infection in a rhesus macaque model for CMV.
Aim 1. Characterize and purify highly potent viral IL-10 neutralizing monoclonal antibodies. Our
preliminary data using active vaccination showed that macaques with strong rhcmvIL-10 neutralizing antibody
responses were significantly protected from horizontal RhCMV infection. We will use PBMC isolated from
those protected macaques to select for B cell clones and use them to produce highly potent vIL-10 neutralizing
antibodies.
Aim 2. Test if viral IL-10 neutralization protects against primary RhCMV infection. Our previous work
demonstrated that rhcmvIL-10 neutralizing antibodies elicited following vaccination with recombinant protein
provided significant protection from horizontal transmission of RhCMV. In this aim, we will determine whether
highly potent rhcmvIL-10 neutralizing monoclonal antibodies provide similar protection, either alone or in
combination with anti-gB antibodies.
Significance. Host immune evasion and modulation by CMV have hindered development of a vaccine to
prevent infection. Targeting cmvIL-10, a key viral immunomodulatory protein, with neutralizing monoclonal
antibodies will open a novel approach to preventing CMV disease that also has potential to impact our
understanding of how to control other pathogens that manipulate host immunity.

Public health relevance
PROJECT NARRATIVE Protection from horizontal cytomegalovirus infection would be of tremendous benefit for global health, particularly for maternal and child health through reduction in the devastating impacts of congenital CMV disease. The goal of this project is to develop a prophylactic treatment to reduce CMV infection using a novel passive immunization approach – targeting the viral IL-10 immunomodulatory protein with a neutralizing monoclonal antibody. This approach has immediate potential to protect women and their developing fetus during pregnancy in addition to potential for a broader impact on vaccine development strategies, specifically targeting immune modulatory proteins.